Implementation of the Animal Feed Regulatory Program Standards (AFRPS) and ISO 17025:2005 Laboratory Accreditation

Abstract for RFA-FD-15-021: Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) Submitting Agency: Nebraska Department of Agriculture 301 Centennial Mall South Lincoln, NE 68509 The Nebraska Department of Agriculture (NDA), including the Commercial Feed Program and the Feed, Fertilizer, and Agricultural Lime Laboratory (FFAL), is eager to participate in RFA-FD-15-021 Competition C, Implementation of the Animal Feed Regulatory Program Standards. We are looking forward to reaching significant to full implementation of AFRPS and to achieving ISO 17025:2005 laboratory accreditation, as this will more closely align the NDA with federal and state efforts. This application will describe the suitability of our Commercial Feed Program and laboratory capabilities in a detailed five year plan to achieve these overarching goals. We are confident that the vast history of cooperation with the U.S. Food and Drug Administration (FDA) and the detailed proposal, will demonstrate how NDA is well positioned to provide the services requested to implement AFRPS and develop a national Integrated Food Safety System (IFSS). Key personnel and administrative support, as described in our FDA Biosketches, indicate our robust qualifications and demonstrate our abilities and determination for success.

Public health relevance
Narrative for RFA-FD-15-021: Implementation of the Animal Feed Regulatory Program Standards (AFRPS) (U18) Submitting Agency: Nebraska Department of Agriculture 301 Centennial Mall South Lincoln, NE 68509 The Nebraska Department of Agriculture (NDA) and the Feed, Fertilizer, and Agricultural Lime (FFAL) Laboratory are prepared to achieve and sustain implementation of AFRPS and ISO 17025:2005 laboratory accreditation. NDA first became enrolled in AFRPS under the elective option of the feed safety inspection contract on July 9, 2014. Acceptance of this cooperative agreement application will allow NDA to overcome the identified and potential challenges observed during the baseline evaluation not only by providing needed resources, but also by offering a structured framework to help achieve the project goals. Key to the success of the project goals will be the addition of qualified personnel, who will be of great value during procedure development and implementation. Information Technology improvements will also play a vital role in meeting verification requirements of the project goals. In addition; data retrieval, submission, and queries will be streamlined through further enhancement of the electronic systems utilized for program and laboratory activities. The purpose of this cooperative agreement application is to develop a risk-based feed safety regulatory program with better directed activities that will enhance feed safety across the state and nation; and to achieve laboratory accreditation under the international standard ISO 17025:2005. NDA is mindful that strategy to achieve these goals is a foundation of the Partnership for Food Protection; which is to develop an Integrated Food Safety System through implementation and uniform application of model standards so that federal, state, territorial, tribal, and local regulatory agencies conduct inspections under the same set of standards. These dynamic principles are further reinforced by the Food Safety Modernization Act. Nebraska ranks amongst the highest across the nation in production of several agricultural commodities; and, as such, is a key player in the U.S. feed industry. The AFRPS principles align with the long-term vision of NDA to develop programs to promote agriculture and uniformly enforce state statutes regulating industries. Furthermore; the vast history of collaboration with FDA, the robust personnel qualifications, and the overarching determination for success demonstrate how NDA is well positioned to provide the services requested in this funding opportunity announcement.